Resource Core

Musculoskeletal (MSK) conditions are the leading contributor to disability worldwide. There is a reciprocal and
perpetuating relationship between the MSK system and chronic disease. Chronic health conditions contribute to
abnormal muscle and bone leading to fractures and impairments in physical function and mobility. The MSK and
mobility changes feedback to increase morbidity and mortality in chronic disease contributing to a cycle of
adverse outcomes. The overarching goal of the Indiana Core Center for Clinical Research (ICCCR) – the Indiana
Center for Musculoskeletal Health Clinical Research Center (ICMH-CRC) is to provide resources and
training to enhance clinical research to improve MSK health across a broad range of diseases and populations.
In our initial P30 funding period, the Function, Imaging, and Tissue Resource Core (FIT Core) was developed
to provide outcomes to generate MSK phenotypes at the functional (i.e. physical function) & morphological (i.e.
organ- & tissue-level properties) levels. The core offered a battery of standardized physical function tests in
research and community participants via a centralized Institutional Review Board protocol, operationalized MSK
imaging resources developing a centralized resource for investigators to navigate, access, and obtain MSK
outcomes, and partnered with the CTSI-supported Indiana Biobank to create a unique biospecimen and tissue
resource. In collaboration with the MSK Informatics Methodology (MIM) Core, the FIT Core linked physical
function and imaging outcomes with biospecimens and an individual’s electronic health record to enable
investigators to formulate and address novel questions related to MSK health. In addition, the FIT Core used the
data it collected to develop and disseminate novel normative data calculators and scorecards for physical
function and high-resolution peripheral quantitative computed tomography outcomes. In the proposed funding
period, growth of the FIT Core will be fostered by taking the Core “on the road” to community health centers and
organizations to diversify the tested population and develop race and ethnicity specific normative data. We will
continue to innovate imaging outcomes to meet investigator needs and expand the number and access to
specimens related to MSK health in the Indiana Biobank. We will also perform whole exome sequencing on DNA
collected from participants to expand the utility of the functional (physical function), morphologic (imaging), and
computable (electronic health record) phenotypes by linking with genomic data. These goals will serve to
overcome barriers of incorporating MSK outcomes in non-traditional fields of study and generate unique
resources to promote and advance clinical research in MSK disorders.